Role of heme and PGP matrikines in lung inflammation

PROJECT SUMMARY:
Sepsis-related acute lung injury (ALI), characterized by increased lung permeability and inflammation remains a
significant cause of death in critically ill individuals. Several inflammatory mediators and mechanisms underlying
increased lung leak have been identified, which while leading to improved therapeutics, have plateaued
suggesting as yet undefined mechanisms, and / or interactions between distinct mediators. In this proposal, we
build upon our preliminary data showing that proline-glycine-proline (PGP) peptides derived from the matrix
protein collagen, are increased in human and murine models of sepsis, and that these matrikines promote lung
leak via CXCR2 activation. In this application, we address the following three questions i) What mechanisms
regulate PGP formation? We hypothesize that free heme, a newly identified mediator of sepsis pathogenesis,
stimulates the release of exosomes containing active prolyl endopeptidase (PE), a protease that catalyzes the
terminal step of collagen breakdown to PGP in the extracellular compartment. Preliminary data show scavenging
of heme by hemopexin decreases circulating PGP levels in vivo; ii) Does endogenous PGP mediate sepsis
induced lung permeability? Preliminary data show that administration of Arg-Thr-Arg (RTR), a peptide that
selectively binds and inhibits PGP, prevents lung leak in vitro and vivo; iii) Does PGP associate with severity of
disease and ALI in human sepsis? Preliminary data show increases in circulating PGP peptides in human sepsis
and demonstrate that this is able to elicit pro-permeability signaling. We propose 3 aims to test our hypothesis
that PGP matrikines mediate sepsis-ALI, SA1: Determine the role and mechanisms by which free heme
mediates PGP peptide formation. SA2: Determine the role and mechanisms by which PGP mediates sepsis-ALI
and SA3: Determine whether plasma levels of free heme, PE-exosomes, and PGP peptides correlate both
clinical outcomes and development of lung injury in patients with sepsis. We propose to use a combination of
primary human epithelial cells, pulmonary microvascular endothelial cells and the cecal-ligation puncture model
of sepsis using C57Bl/6 male and female mice to test our hypothesis, and couple this with biochemical and
molecular approaches to measure protease activity, free heme levels, exosomes and PGP peptide levels.
Mechanistic insights will be gained using selective inhibitors of heme, PGP and proteases that generate PGP,
as well as a novel endothelial targeted CXCR2-/- mouse model generated for the proposed studies. Successful
completion of these aims will significantly improve our understanding of mechanisms underlying sepsis-ALI with
a specific emphasis on protease containing exosomes and matrikines as new mediators and therapeutic targets
in this debilitating disorder.

Public health relevance
Acute Lung injury is a critical public health problem with a high associated morbidity and mortality. The exact mechanisms operative in this dysfunction are unknown. Our proposal will examine if an extracellular matrix- derived peptide and circulating heme may mediate acute lung inflammation and whether targeting them therapeutically provides protection.